Linking Daily Parental PACEs to Parenting and Preschoolers' Self-Regulation Growth: A Burst-Design Longitudinal Study

Parental adverse childhood experiences (ACEs) can impact the next generation’s self-regulation (SR) development via
disrupted parental stress response and decreased parenting quality. The intergenerational and cumulative adverse and
resilient experiences (ICARE) model emphasizes that ACEs can transmit intergenerationally, and development is a
neurobiological adaptation to both stress and protective and compensatory experiences (PACEs). Accordingly, the
protective effects of PACEs against ACEs should be seen as a dynamic interplay between contexts and development.
Existing literature on PACEs, stress, parenting, and child SR development relies primarily on between-person
comparisons, assuming PACEs, parenting, and child SR as relatively static constructs. Emerging empirical evidence
captured short-term changes in PACEs, parenting, and SR, indicating the way parental PACEs are linked to child SR
is a dynamic within-person process. No previous studies have examined the within-person dynamic relation between
daily PACEs, parental stress, parenting, and long-term child SR development. The proposed study will examine the
dynamic daily interplay among parental PACEs, stress, parenting, and child SR and examine the link between
dynamic interplay and long-term SR growth. A sub-sample of the study will examine whether parents and their
preschoolers’ heart rate variability captured by wrist wearables corresponds with parent-report parental stress and
child SR.
The proposed study combines intensive longitudinal design and traditional longitudinal design, which allows
researchers to account for heterogeneity in the dynamic process from PACEs to SR as well as the long-term outcomes.
The proposed project will also examine whether parental daily PACEs are associated with elevated daily stress and
decreased parental intrusiveness and elevated parental sensitivity, which in turn, is related to better preschoolers’ daily
SR and bigger one-year growth in SR. This study can provide data supporting larger-scale studies that examine
within-family mechanisms from PACEs to child SR among parents with different histories of ACEs. Understanding
the within-person dynamic pathway from PACEs to long-term child SR growth allows future intervention scientists to
stop the intergenerational transmission of ACEs through real-time promotion of parenting quality and child SR.

Public health relevance
ACEs are risk factors for poor physical and mental health outcomes, which can impact more than one generation. Children with lower SR are more likely to have lower academic achievement and worse health and wealth outcomes in the long term. ACEs can have such a long and deep impact on multiple generations of people, causing health and financial burdens for the nation. Identifying protective factors that can disrupt the intergenerational transmission of ACEs can promote public health’s well-being and encourage the next generation to grow up to be functional and healthy individuals.